PHARMACOKINETICS AND EFFECTS OF VITAMIN K IN WOMEN OF CHILD BEARING AGE

In preparation for the possibility of giving pregnant women Vitamin K to prevent K-deficient infants, this research involves study of absorption, clearance and chemical behavior of the vitamin administered to healthy, non-pregnant women of child bearing age.